Unraveling the Structural Architecture and Molecular Mechanisms of HIV-1 Cell-to-Cell

Project summary
HIV-1 cell-to-cell transmission is a highly efficient mode of viral spread that evades
immune surveillance and antiviral therapy, contributing to reservoir formation and
disease persistence. Despite this critical role, the mechanism by which cell-to-cell
transmission enables this evasion of antiretroviral therapies and immune responses
remains poorly understood. In particular, the architecture of HIV-1 transmission sites
in their native, frozen-hydrated state has been challenging. Previous imaging
techniques, such as traditional electron microscopy, have been limited by sample
preparation artifacts that obscure the true structural details of these transmission
sites.
Our proposal aims to use advanced in situ correlative cryoimaging techniques to
explore the ultrastructure of HIV-1 cell-to-cell transmission in primary T lymphocytes.
Preliminary data using this approach challenges the prevailing hypothesis that viral
transmission requires numerous viruses in a large intercellular space. Instead, our
findings suggest that transmission occurs in small, confined spaces containing only
1-3 viruses, enclosed by narrow membrane interfaces that may hinder access by
broadly neutralizing antibodies and antiviral drugs.
Through two specific aims, we will (1) determine the architecture of HIV-1
transmission sites in primary T cells using correlative in situ cryoimaging and (2)
investigate the molecular determinants of viral entry and infection in both free-virus
and cell-to-cell transmission. The outcome of this research are insights into the
mechanisms driving efficient viral spread which can inform therapeutic strategies
specifically designed to target and impair cell-to-cell transmission—a critical aspect
currently overlooked in existing treatments.

Public health relevance
Project Narrative HIV-1 cell-to-cell transmission contributes to viral spread and reservoir formation, complicating eradication efforts. By employing in situ correlative cryoimaging, this project aims to reveal how HIV-1 evades both immune surveillance and therapeutic interventions, including broadly neutralizing antibodies. Understanding these aspects will be pivotal in developing targeted strategies to impair cell-to-cell transmission, potentially enhancing the efficacy of current passive immunization approaches and improving overall HIV treatment outcomes.